Repeat STI Patients: Tailored Socio-Contextual Intervention to Reduce HIV Risk

DESCRIPTION (provided by applicant): Repeat sexually transmitted infections (STI), such as Chlamydia, gonorrhea, trichomoniasis, and syphilis indicate persistent elevated risk activity for HIV, and repeated STI infections increase the likelihood of HIV transmission during exposure. Repeat STI patients represent a significant proportion of public STI clinic visits. Patients who seek treatment for repeat STI infections, by definition, are not adequately served by the prevention services currently provided by STI clinics, and may benefit from additional clinic-based services to reduce their risk of future infections of STI and HIV. The HIV prevention field has largely been silent about assisting repeat STI patients; there are no published studies testing interventions specifically for this population. In addition, most HIV risk-reduction intervention research based in STI clinics has focused directly on the presenting problem of sexual risk behavior, at most addressing one other related factor, such as co- existing depression or substance use, in a single study, whereas it is clear that repeat STI is driven by a wide range of contextual factors. Novel, individually tailored intervention approaches are likely needed to help repeat STI patients reduce their risk of HIV infection and infecting others. We propose to address these limitations of previous research by developing and testing an individually-tailored strengths-based prevention case management intervention strategy based on Social Action Theory (Ewart, 1991) that addresses repeat STI patients' social context and other factors that heighten STI and HIV risk among these patients. This research will be conducted in two phases. During the first 12-15 months of the project, our efforts will be devoted to conducting formative research on the phenomenon of repeat STI in Milwaukee, WI, a city with high and rising rates of STI, and on developing and piloting the intervention protocol. Our formative work will consist of three major elements. First we will conduct qualitative interviews with a sample of repeat STI patients to better understand the factors that lead to their repeated infection and what services they believe could help them avoid future infections. Second, we will develop an individually tailored clinic-based intervention to reduce risk among repeat STI patients. Third, we will conduct a feasibility and acceptability trial of the intervention. In the second phase of the project, we will conduct a full randomized clinical trial with 250 men and 250 women attending the clinic with two or more STI in a 12 month period. We will follow participants in the experimental group and the control group (clinic standard care) for 12 months following recruitment to examine the effects of the intervention on sexual risk activity, repeat STI, and other beneficial health effects. Finally, we will conduct a cost and cost-effectiveness analysis of the intervention.

Public health relevance
PUBLIC HEALTH RELEVANCE: We propose to develop an intervention that will reduce the potential for HIV infection and other health risks among patients with repeat sexually transmitted infections. We expect that the planned intervention will also have broader positive effects on patients' social context, ability to plan for the future, and quality of life, which may result in positive health effects in other areas as well. By developing an individualized intervention to help these patients to reduce their exposure to infection with HIV and other STIs we expect the intervention could be used in many US STI clinics to reduce the burden of STI and risk for HIV among these patients, their partners, and health systems. We propose to develop an intervention that will reduce the potential for HIV infection and other health risks among patients with repeat sexually transmitted infections. We expect that the planned intervention will also have broader positive effects on patients' social context, ability to plan for the future, and quality of life, which may result in positive health effects in other areas as well. By developing an individualized intervention to help these patients to reduce their exposure to infection with HIV and other STIs we expect the intervention could be used in many US STI clinics to reduce the burden of STI and risk for HIV among these patients, their partners, and health systems. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS This revised application requests funding for a five-year project to develop and test an intervention to reduce risk among people at high vulnerability for HIV infection: patients who present repeatedly at sexually transmitted infection clinics. Repeat bacterial sexually transmitted infections (STI) such as chlamydia, gonorrhea, trichomoniasis, and syphilis, and repeat visits to STI clinics for exposure and potential infection, indicate persistent high-risk sexual behavior. Recidivist patients further represent a significant proportion of public STI clinic visits. Repeat STI can increase the likelihood of HIV transmission during exposure and some recidivist patients may serve as "core transmitters," propagating an ongoing epidemic or endemic chain within a community. Repeat STI patients also face serious health risks from STI complications. In sum, STI repeaters present significant public health risks and place a large financial and resource burden on treatment systems. Patients with repeat STI, by definition, are not adequately served by the prevention services currently provided by STI clinics. Thus, additional clinic-based services to reduce their risk of future infections of STI and HIV are warranted. Adequately addressing the needs of repeat STI patients will allow limited resources to be more heavily invested in services for first-time STI patients who are more likely than recidivist patients to be amenable to standard clinic-based risk-reduction interventions. The HIV prevention field has largely been silent about assisting patients who present repeatedly with STI and STI risk; there are no published studies testing interventions specifically for repeat STI patients. In addition, most risk-reduction intervention research based in STI clinics has focused directly on the presenting problem of sexual risk behavior or addressed a single co-existing factor (e.g., substance use, depression). However, research suggests that repeat STI is related to a wide-ranging and complex configuration of contextual factors that varies by patient. Indeed, repeat STI is highest among communities with the highest rates of STI in general, which are characterized by myriad contextual challenges (e.g., unemployment, poverty). Novel intervention approaches are needed to help repeat STI patients reduce their risk for HIV infection and for infecting others. We propose to address these gaps in the HIV and STI prevention literature by focusing on a high-risk group of recidivist patients: economically disadvantaged urban African Americans. Our intervention will help patients address broader, "risk-regulating" social and contextual factors identified by each patient (e.g., employment, housing, domestic violence, substance abuse). We also will address individual risk behavior and affective and self-regulatory factors (e.g., fatalism, problem solving skills), that contribute to continued risk behavior and interfere with maintenance of risk reduction after an STI. The Primary Aims of the proposed research are to: (1) Develop and test a novel clinic-based intervention for repeat STI patients, in the City of Milwaukee Keenan Health Center, a large urban public STI clinic primarily serving low-income African American patients. (2) Test the effects of the intervention compared to standard STI clinic care, using both quantitative and qualitative analyses. (3) Determine the cost-effectiveness of the newly developed intervention. The Primary Aims will be accomplished through the following steps: (1) In Phase I, develop the intervention, using input from qualitative interviews with repeat STI patients, input from consultants, and pilot testing. Based on the existing literature on repeat STI and Social Action Theory (SAT; Ewart, 1991), we anticipate that the new intervention will consist of two face-to-face sessions employing a Strengths Model case management approach (Rapp & Goscha, 2006) to HIV prevention case management. This expanded, strength-based, prevention case management (SBPCM) intervention, consistent with a SAT conceptualization of repeat STI, is designed to increase patients' self-regulatory abilities, address internal affective states that contribute to continued risk, and assist participants' to actively address broader socio-contextual issues that contribute to risk. The formative phase will also ensure the acceptability and feasibility of the intervention among repeat STI patients. (2) In Phase II, recruit and enroll into an intervention trial 500 participants (50% women; predominantly African American). All will have been treated for a separate STI episode in the past 12 months at the same clinic. (3) After they receive standard STI diagnosis, treatment, and partner notification services, randomly assign participants to one of two conditions: A. The individualized, STI SBPCM approach developed in Phase I. As part of this intervention, in addition to the two planned individually-tailored sessions, staff will facilitate referrals for patients to access services and treatment from local agencies that have been engaged in the research project and have agreed to take referrals with regard to broader "risk regulating" social and contextual factors identified by each patient. The prevention case managers will follow up with each participant using a structured schedule of three phone contacts over a two-month period to discuss progress in addressing the identified problems, encourage their engagement with the referral agencies, and to provide additional support and referrals. B. The clinic's standard risk reduction approach for all patients, which includes brief risk screening and informational brochures regarding social services. (4) Assess participants' sexual risk behavior, determinants of risk behavior guided by Social Action Theory, and other measures of quality of life at baseline, 4, 8, and 12 month follow ups, using computerized assessments to reduce reporting biases. We will assess the incidence of new STI by conducing STI and HIV testing at the 12-month follow up as well as electronic chart reviews of the entire 12-month follow up period, which will indicate STIs treated at the target clinic as well as at other sites in Wisconsin. We will use these data to test the efficacy of the experimental intervention relative to the control condition and to conduct theory-based analyses of mediators of intervention outcome. (5) Conduct a thorough qualitative end-of-program evaluation of participants' experience. We will sample from participants in the experimental intervention group who experienced another STI during the follow up period as well as those who did not. (6) Conduct cost and cost-effectiveness analyses to assess the incremental cost and the incremental cost effectiveness of the prevention case management, compared to the standard of care, and to determine whether the experimental intervention is an affordable and economically-efficient approach to reducing HIV infection among repeat STI clinic patients. Given the prevalence of repeat STI, repeat patients' risk for becoming HIV infected, and their risk for spreading STI and HIV within a community, an effective intervention is needed for this population. The proposed study will be the first to test a risk reduction intervention specifically designed for repeat STI patients. Further, the study will produce valuable information regarding the benefits of addressing broader 'risk regulating' socio-contextual factors within a HIV and STI prevention intervention integrated into an STI clinic setting. Developing an effective, individually tailored intervention for repeat STI patients may lead to significant reductions in STI and HIV. If the intervention is effective and cost-effective, dissemination and implementation on a wide scale in community-based clinics can assist patients to reduce sexual risk behavior and make improvements in other important areas of their lives, resulting in other health and social benefits.